Mitigating Developmental Neurotoxicity Through Maternal and Offspring Exercise

Project Summary/Abstract
Benzo[a]pyrene (BaP) is a known carcinogen and ranked 8th on the U.S. government’s Priority
Pollutants List while the entire class of compounds (polycyclic aromatic hydrocarbons or PAHs) ranks 9th.
Human exposures are widespread from traffic-related air pollution, wildfires, cigarette smoke, and grilled foods
and nearly impossible to avoid. Recent human studies found strong correlations between prenatal PAH
exposure and persistent cognitive and behavioral deficits in exposed children. We recently reported results
from a mouse study demonstrating that genetic differences in the aryl hydrocarbon receptor (AHR) and
CYP1A2 increase risk following developmental exposure to BaP. AhrbCyp1a2(-/-) mice with the high-affinity
AHR and AhrdCyp1a2(-/-) mice with the poor-affinity receptor both had impaired performance in the Morris
water maze test of spatial learning and memory. High-affinity Ahr knockouts also had motor deficits in Rotarod,
and poor-affinity knockouts exhibited higher levels of anxiety-like behavior. The benefits of regular exercise on
brain health are well established, but considerably less is known about the effects of exercise during
pregnancy on the health of the mother and brain function in her offspring. The neurological benefits of exercise
include increased levels of brain-derived neurotrophic factor (BDNF) and beneficial modifications of
neurosignaling by serotonin, dopamine and noradrenaline. The mechanism of action for aerobic exercise
benefits on hippocampal dependent learning and memory were directly tied to BDNF signaling. Both maternal
and offspring exercise have been successful in reversing spatial learning and memory deficits induced by
prenatal stress. Exercise during early life has additional benefits on improving mood and reducing levels of
stress hormones whereas anxiety-like behavior is increased in mice with a knockdown of the BDNF receptor
TrkB. We conducted pilot studies in C57BL/6J mice and found that both maternal and offspring voluntary wheel
running increased circulating BDNF levels. Our proposed studies will use aerobic exercise to increase
BDNF levels in offspring exposed to BaP during early brain development with the goal of rescuing the
neurological deficits observed in our previous studies. First, we will compare the relative effectiveness of
four different exercise treatments and ensure they do not cause harm to the dam or pups. Next, we will use the
exercise regimen determined to be safe and most effective in an attempt to rescue learning and memory and
motor deficits and to reduce anxiety-like behavior in our most susceptible mouse lines.The translational value
of these studies is high, because we seek to identify the minimum level of exercise necessary to produce
beneficial effects. This greatly increases the feasibility of compliance in the human population.

Public health relevance
Project Narrative Although we know that prenatal and early life exposure to chemicals found in traffic-related air pollution (TRAP), grilled food, wildfire and cigarette smoke leads to adverse effects of learning, memory and behavior, it is extremely difficult to reduce these exposures in the general population. This study will use a mouse model to develop and validate a simple intervention to mitigate the adverse effects by incorporating exercise for both the mother and her offspring. A critical aspect of this study will be determining the duration and intensity of exercise that is both safe and effective.